ONC201/TIC10 Anti-tumor Effect Through Regulation of the TRAIL pathway

PROJECT SUMMARY
The project addresses the problem of drug resistance in cancer which is arguably the most important
problem facing patients with advanced cancer. While advances have been made in targeted therapy and
immunotherapy, over 600,000 Americans will die in 2018 from cancer. Over the last two decades, we
discovered TRAIL receptor DR5 and resistance mechanisms in cancer, identified drug synergies, and
discovered small molecule ONC201 as a first-in-class TRAIL pathway inducer. Based on the novelty of
ONC201, its emerging mechanism of action, the specific impact my lab can have on the field and on
patients, this proposal will focus in depth on ONC201 preclinical mechanistic directions. ONC201 has
progressed as a monotherapy into multiple clinical trials with various tumor types. Our studies are
providing important basic information regarding the mechanism of action of ONC201 involving TRAIL
induction after dual blockade of ERK and Akt converging on Foxo3a to activate TRAIL, and an integrated
stress response that involves eIF2-alpha dependent ATF4/CHOP-mediated induction of TRAIL death
receptor 5. ONC201 depletes colorectal cancer stem cells and with dose intensification in mice we
observed anti-metastasis effects, inhibition of cell migration, and infiltration by NK and T cells into treated
tumors (recently published by Wagner et al., J. Clin. Invest., 2018). Our data has led to a change in
clinical dosing in all open clinical trials including at Fox Chase Cancer Center (NCT02609230). Our
specific aims include: Aim #1: Investigate ONC201 effects on the tumor microenvironment through NK
and T cells leading to anti-tumor and anti-metastasis effects. Aim #2: Investigate the role of the immediate
binding target for ONC201, the sub-family of dopamine receptors DRD2/DRD3, in mediating its anti-
tumor effects. We will explore novel connections between antagonism of the putative specific drug
binding target dopamine receptor D2 and D3, the TRAIL and integrated stress pathway mechanism
triggered by ONC201, their status in normal vs tumor cells, and sensitive vs resistant cells or tumors from
patients exposed to ONC201. Our studies include in depth mechanism analysis of the immune
stimulatory effects of ONC201, including analysis of immune infiltration by different immune cell subsets,
various cytokines involved in attracting immune cells to tumors or those that may be potentially immune-
suppressive, and use of TRAIL and DR5 knockout as well as NCR1-GFP mice with GFP(+) NK cells to
analyze host tumor interactions of ONC201 (or ONC201 analogue) treated tumors. We explore ONC201
resistance mechanisms through molecular profiling of tumor specimens from ONC201 trials and critically
assess their role in preclinical models.

Public health relevance
PROJECT NARRATIVE This research program is directed towards the highly significant problem of drug resistance in advanced cancer that may be addressed by targeting anti-tumor cell death signaling pathways. The proposal builds on discovery in the El-Deiry Lab of a new drug ONC201 targeting the TRAIL death receptor pathway that has been brought into multiple clinical trials and is showing promising activity in multiple tumor types including prostate cancer, GBM, uterine cancer, lymphoma, leukemia and colorectal cancer. The proposal provides unique and novel mechanistic insights regarding signaling within tumor cells including immune stimulation by ONC201, involvement of dopamine receptors, and explores drug resistance mechanisms.